COBRE Center for Antimicrobial Resistance and Therapeutic Discovery - Administrative Core

The Miriam Hospital enthusiastically recommends Erika D’Agata, MD, MPH of to be appointed as The Center for Antimicrobial Resistance and Therapeutic Discover (CARTD) Program Director/Principal Investigator (PD/PI) effective March 1, 2023.

Administrative Core
Summary/Abstract
The Administrative Core will provide financial, scientific and technologic stewardship of the
COBRE Center for Antimicrobial Resistance and Therapeutic Discovery (CARTD) at The Miriam
Hospital. Core Director Mylonakis, with the assistance of Deputy Director Nau, will establish
overall programmatic goals. These goals and progress toward accomplishing them will be
monitored by the Steering Committee, External Advisory Committee, Senior Faculty Mentoring
and Advisory Committee (SFMAC) and Program Staff at NIGMS. Our Center’s overall mission is
to foster an environment that inspires individuals to pursue rigorous laboratory science by
providing technical and mentoring support through our core facilities. We will pursue the
following specific aims: (1): The Core will maintain an organizational structure that ensures
effective communication between the supervisory, scientific, administrative and service oriented
components of the COBRE. (2): The Core will devise strategies to increase the use of CARDT
Cores to allow self-sustainability by the end of Phase III. (3): The Core will provide a rigorous
mentoring infrastructure to all CARDT principal/pilot investigators. (4): The Core will manage a
Pilot Grants Program designed to support the most meritorious research on antimicrobial
resistance and drug development.